UW PET/CT Acquisition

PROJECT SUMMARY/ABSTRACT
The objective of this proposal is to purchase a state-of-the-art microPET/CT small animal imaging scanner for
the University of Wisconsin Small Animal Imaging and Radiotherapy Facility (SAIRF), which will function as a
long-term shared resource for NIH-funded investigators at the UW School of Medicine and Public Health (UW
SMPH). Specific aims include: Aim 1: To improve the productivity of small animal imaging research at the UW
SMPH by making a state-of-the-art microPET/CT scanner accessible to federally-funded investigators, Aim 2:
To enhance the ability of these investigators to perform high resolution PET and CT scanning to determine
cancer treatment efficacy, biological basis of disease and using-imaging based dosimetry to provide more
accurate radiotherapy dosing, and Aim 3: To foster the development of new small animal imaging resources that
efficiently use the personnel and shared facility resources at the UW SMPH and UWCCC. The SAIRF provides
support to faculty and trainees working on small animal imaging research projects. The laboratory offers high-
quality multimodality image acquisition and analyses and consultative services on a fee-for-service basis
available to the campus community and beyond. Our Siemens Inveon microPET/CT is at the end of its life and
will not be supported past 2024. With this S10 grant application, we seek to replace the Inveon with a high
resolution, sensitivity, and uniformity system with a compact footprint that will yield accurate quantitative data
and allow seamless continuation of research for our cancer center members and University researchers. An
acquisition of the Molecubes β-CUBE/X-CUBE small animal scanner meets all of these needs. This will facilitate
and enhance the scientific quality and productivity of numerous NIH-funded research projects. The research
programs that will use the new shared instrument seek to better understand cancer biology, the effects of external
beam radiation and targeted radionuclide therapy (TRT) on tumor microenvironment, to combine radiation,
including TRT, with immunotherapies with the intent of affording durable curative cancer responses accompanied
with immune memory induction. The Major Users group consists of RO1, PO1, UO1, and DOD-funded
investigators, while the Minor Users group also includes U54, P01, RO1 and DOD-funded investigators who
request this instrument to achieve their specific aims. Exceptional departmental and institutional support
(providing 41% of the purchase price) and outstanding technical expertise assure that the requested equipment
will be operable immediately and highly productive at UW for many years to come.

Public health relevance
PROJECT NARRATIVE Positron Emission Tomography (PET) /Computed Tomography (PET/CT) is critical for the development of new molecularly targeted radiopharmaceuticals for imaging and theranostic treatment of cancer. The role of the University of Wisconsin Carbone Cancer Center Small Animal Imaging and Radiotherapy Facility (SAIRF) expanded recently in response to a large influx of grants utilizing targeted radionuclide therapy to enhance tumor response to immunotherapy. This proposal is intended to purchase a state-of-the-art, high resolution microPET/CT scanner, replacing our existing and soon-to-be unsupported Siemens Inveon microPET/CT which is currently the only microPET/CT scanner in Wisconsin.